Administrative Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Administrative Core is to support the objectives of the MATCHES Telehealth Research
Center by serving as the organizational hub to optimize collaboration and scientific interactivity among
MATCHES (Making Telehealth Delivery of Cancer care at Home Effective and Safe) investigators. The
services centralized in the Administrative Core provide the scientific, administrative, communications, and
fiscal infrastructure that serves all components of the proposed P50 Program. The specific aims of the
Administrative Core are to: 1) maximize operational efficiency through coordination, communication, execution,
and oversight of all Center activities; 2) engage and foster synergy and knowledge exchange among Center
members; national experts in telehealth and health system performance; and patients, leaders and workforce;
3) provide training opportunities for investigators from diverse backgrounds and disciplines, equipping them
with infrastructure, resources, skills, and mentorship to foster innovation and expand the evidence base for
when and how to integrate telehealth into cancer care; and, 4) support Center activities with strong theoretical
models, conceptual frameworks, and approaches for implementation and overall impact. The Core will
organize meetings and coordinate a Center website to disseminate knowledge; obtain ongoing feedback from
both national experts in telehealth and MSK leaders; and engage with diverse stakeholders across all Center
activities. The Core will evaluate the capacity for telehealth to enable patients to receive safe, equitable, and
effective oncology care in their own homes using the MSK@Home platform that includes support for laboratory
tests, nursing, and pharmacy supervision without necessitating a clinic visit. The Core will prioritize
measurement of the digital divide and provide the support necessary to mitigate disparities among patients at
high risk for poor-quality care resulting from racism, age, poverty, or disability. It will track utilization metrics
and help implement strategies to support equitable access, including provision of training, equipment, and web
access. To fulfill the Center's education and mentoring mission, the Core will recruit postdoctoral fellows and
provide opportunities for young investigators to learn from senior researchers in collaboration with the
Research & Methods Core. The Administrative Core will be led by M. Morris, MD, K. Panageas, DrPH, and
P.D. Stetson, MD, the PIs of MATCHES, with support from a dedicated Center Manager. This Executive Team
will share overall authority for the scientific and administrative decision-making and for the day-to-day running
of MATCHES. The Core will include six support units—Regulatory and Fiscal Unit, Clinician and Staff
Engagement Unit, Patient Engagement Unit, Training Unit, Internal Advisory Board, and External Advisory
Board—led by faculty with diverse, synergistic expertise. The Core will use cohesive conceptual frameworks to
ensure that the evidence generated by Center investigators builds on existing knowledge and is informative for
the design of telehealth-based cancer care delivery worldwide.